Molecular Basis of Centromere Specification and Inheritance

PROJECT SUMMARY/ABSTRACT
A fundamental but poorly understood process in eukaryotic cells is how cells structure their genomes into distinct
functional domains. This project addresses this gap in knowledge by studying the centromere, a specific
chromatin domain found in all eukaryotes. This stably propagated locus guides the assembly of kinetochores to
ensure proper segregation of chromosomes during mitosis and meiosis. Mis-regulation of centromeres adversely
affects chromosome segregation resulting in aneuploidy, a condition found in more than 90% of all cancers.
Aneuploidy contributes to the development of many diseases, such as cancer and Down syndrome. The goal of
this project is to understand the molecular mechanisms underlying the specification and inheritance of
centromeres. In most eukaryotes, centromeres are epigenetically governed by the centromere-specific histone
H3 variant, CENP-A. CENP-A partially replaces canonical histone H3 at centromeres, and provides the
foundation for the assembly of kinetochores. Mislocalization of CENP-A to non-centromeric regions has a
devastating impact on chromosome segregation, and has been linked to a variety of cancers. However, how
CENP-A chromatin is assembled at centromeres remains poorly understood. Centromeres in most eukaryotes
can be transcribed at low level, and centromere transcription has been implicated in centromere structure and
function. But how centromere transcription is regulated is still largely unexplored. Interestingly, centromeres in
eukaryotes are usually embedded in epigenetically distinct heterochromatin, the transcriptionally silenced
chromatin domain. Heterochromatin is mainly composed of tandem DNA repeats, and has been shown to
contribute to centromere formation. Nonetheless, how heterochromatin repeats are organized and the precise
role of heterochromatin in centromere assembly remains elusive. In addition, centromeres and heterochromatin
domains in the eukaryotic nucleus typically exhibit distinct patterns of spatial organization, which have been
implicated in 3D genome architecture and regulation. But how centromeres and heterochromatin are spatially
organized remains unclear. We propose to use fission yeast (Schizosaccharomyces pombe) to address these
outstanding questions. Fission yeast is a simple eukaryotic model organism with many aspects of centromere
regulation conserved with humans. It is particularly suited to an interdisciplinary approach that includes genetics,
genomics, cytology, biochemistry, and structural biology. We propose to: 1) define the mechanisms for how
centromere transcription is regulated and its role in centromere function; 2) determine how the heterochromatin
repeats are organized and their contribution to CENP-A chromatin assembly; 3) identify regulatory mechanisms
underlying spatial organization of centromeres and heterochromatin. Given that epigenetic regulation in fission
yeast is conserved, our studies will shed light on the processes governing chromosome segregation in human
cells, and contribute to a better understanding of human diseases resulting from centromere misregulation.

Public health relevance
PROJECT NARRATIVE The centromere is a specific chromatin domain responsible for equal segregation of duplicated chromosomes into daughter cells during cell division. Centromere dysfunction results in an abnormal number of chromosomes in dividing cells, a phenomenon observed in more than 90% of all cancers. The proposed study will advance our understanding of how perturbations in centromere regulation lead to cancer and other diseases, and potentially allow us to design new strategies for the diagnosis and treatment of such diseases.